PHASE I SF 2 RGP120/HIV1 (BIOCINE)

To determine the relative safety and immunogenicity of a panel of adjuvants when administered individually and in combination with a recombinant SF-2 HIV-1 rgp120 envelope protein (Biocine) produced in Chinese Hamster Ovary (CHO) cells; in healthy HIV-1 uninfected volunteers.